Implementation Strategies to Improve Hypertension Treatment in Kenya

PROJECT SUMMARY/ABSTRACT
Hypertension is the leading preventable cause of morbidity and premature mortality globally and is a major driver
of the rising burden of cardiovascular disease (CVD) in sub-Saharan Africa (SSA). Hypertension can be
controlled with highly efficacious, cost-effective medications; however, of the over 100 million people with
hypertension in SSA, 10% or fewer have controlled blood pressure, with similar low rates of control among
people with HIV. There is a strong commitment both in SSA and globally to improve treatment for hypertension
and other CVD risk factors by ensuring medication supply, by leveraging the HIV chronic care model, and via
primary health system strengthening. As hypertension diagnosis and medication availability improve, strategies
are needed to increase patient-centeredness of chronic hypertension care models in order to engage patients in
the long-term care required to reduce CVD risk and achieve optimal health outcomes.
In this K23 proposal, my overall scientific objective is to assess, and test interventions that overcome, patient-
level barriers to hypertension treatment adherence in a chronic HIV-hypertension care model in Kenya. This
proposal is nested within the NIH-funded SEARCH SAPPHIRE trial (U01AI150510) evaluating integrated
hypertension-HIV care in East Africa. In Aim 1, I will use a theory-informed mixed methods approach to evaluate
barriers to hypertension treatment adherence within the SEARCH integrated hypertension-HIV care model. In
Aim 2, I will conduct a discrete choice experiment to assess patient preferences for strategies to improve care
delivery, using findings to develop an implementation strategy to improve patient-centered hypertension care. In
Aim 3, I will conduct a pilot study to assess feasibility and acceptability of this implementation strategy.
My overall training objective is to develop expertise in implementation science approaches to improve the patient-
centeredness and effectiveness of integrated care models for hypertension and HIV in sub-Saharan Africa. My
research aims map to my specific training objectives to: (1) develop expertise in hypertension and CVD clinical
research, (2) learn mixed methods applications in implementation science, (3) learn implementation science
methods for intervention development and evaluation. This K23 proposal is responsive to NHLBI Strategic
Objective 6, to optimize clinical and implementation research to improve health and reduce disease. My
proposed training and research aims will equip me with the necessary skills to achieve my long-term goal of
becoming an independent NIH-funded investigator with expertise in implementation science methods to improve
CVD and HIV outcomes. Findings generated from this proposal will inform an NIH R01 application to test a multi-
component strategy for improving hypertension treatment outcomes among people with and without HIV in SSA.

Public health relevance
PROJECT NARRATIVE There is strong commitment in sub-Saharan Africa, and globally, to improve hypertension treatment as a key part of the global strategy to reduce cardiovascular disease mortality by 25% by the year 2025. As hypertension diagnosis and medication availability improve, there is a critical need for interventions to improve patient- centeredness and patient engagement in chronic hypertension care in order to achieve and maintain the long- term benefits of hypertension treatment. In this K23 proposal, I will develop and pilot test a theory-informed implementation strategy to improve hypertension treatment adherence among people with and without HIV in the context of an integrated chronic HIV-hypertension care model in rural western Kenya.